Neurobehavioral & Psychiatry Core

PROJECT SUMMARY/ABSTRACT: NEUROBEHAVIORAL AND PSYCHIATRY CORE
The NeuroBehavioral and Psychiatry (NBP) Core, previously the Neurobehavioral Unit of the
NeuroAssessment Core from the prior funding period, is a new Core proposed for the competing HNRC renewal.
The new NBP Core will apply assessment expertise in conducting comprehensive neuropsychological,
psychiatric (including both psychiatric diagnoses and dimensional symptom levels), substance use, and daily
functioning assessments. This supports the Center’s new emphasis on neurobehavioral phenotypes among
persons with HIV (PWH), and links them to medical and biological data from other HNRC Cores and associated
studies. NBP aims map directly onto the Office of AIDS Research Priorities under the major topic of “HIV-
associated comorbidities, coinfections, and complications” by addressing areas of neurologic consequences,
mental illness, and health disparities. The goals of the NBP Core are to contribute to the identification of
individuals who have evidenced changes in cognition, depression and daily functioning, and to provide
comprehensive longitudinal neurocognitive, psychiatric, substance use and everyday functioning assessments
on the PWH and HIV- comparison participants. Importantly, our core will provide the neuropsychological and
psychiatric (including depression) assessments in order to determine neurobehavioral phenotypes. We aim to
facilitate and enhance multidisciplinary research in neuroHIV by providing a range of services, training and
scientific consultation to projects such as investigator-driven R01s, R21s, and R34s, international neuroHIV
studies, and a variety of intra- and extramural investigations. Historically, the NBP Core and its investigators
have been national and international leaders in the neuroHIV field, spurring the development of both international
harmonization of assessments and new methods, while adapting to the continually evolving scientific landscape.
We aim to continue in this regard. In addition, in support of the HNRC’s increased focus on combined
neurobehavioral phenotypes among PWH, and participants who change over time, the NBP Core will administer
a more detailed psychiatric assessment which will examine detailed components of depression (e.g., anhedonia,
apathy), anxiety, stress, adverse childhood events and life trauma, and resilience and social support. All of these
factors may influence the complex relationships among neurocognition, depression, HIV disease and other
clinical outcomes. We will work hand-in-hand with 1) the NeuroMedical Core to identify underlying biological
mechanisms of neurobehavioral phenotypes, exploring connections to HIV disease (e.g., CSF viral load),
inflammatory processes/biomarkers (e.g., IL-6), other medical comorbidities (e.g., metabolic syndrome), co-
infections (e.g., CMV; NM and NVB Cores); and 2) with the MIBI Core to explore effects of microbiome and
metabolome on neurobehavioral outcomes and/or phenotypes; and with both NM and NVB Cores regarding
neuroinflammation and long-term protective and/or neurotoxic effects of antiretrovirals.